PHARMACOGENETICS OF ALFENTANIL METABOLISM &CORRELATION WITH CYTOCHROME P450IIIA

Determine the pharmacogenetics of alfentanil metabolism with particular reference to cytochrome P450IIIA activity, and determine the correlation of alfentanil pharmacokinetics with the activity of P450IIIA4, reflected by the C14-erythromycin breath test determined in a separate protocol.